Ontogeny of Central Neural Taste Responses

Project Summary/Abstract
The developing gustatory system is characterized by impressive structural and functional changes. The central
taste pathway in rodents is especially plastic during normal development, even at the first synaptic relay.
Structurally, the terminations (i.e., terminal fields) of neurons carrying taste information from taste buds to the
nucleus of the solitary tract (NST) in the medulla are reduced in size, or “pruned”, to about half of their size --
beginning just before weaning and extending for about 10 days after weaning. Functionally, the period of
“pruning” occurs coincident with the increase in taste-elicited neural activity in gustatory nerves, suggesting a
requisite activity-dependent component. Moreover, experimental manipulations of neural activity and the
animal’s dietary history during development interrupts the normal “pruning” of terminal fields, indicating that
both activity-dependent and activity-independent factors play a role in the developmental process of circuit
refinement. The long-term goal of this project is to understand how the central gustatory system is assembled
and then refined by experience. The specific aims of this proposal examine 1) how neurons that innervate
single taste buds on the anterior 2/3 of the tongue map onto the NST and how the projections change during
normal development and in adult mice that have altered neural activity throughout development or an altered
dietary history, and 2) how the neuro-immune molecular cascade operating during normal development is
interrupted in mice that have altered neural activity or an altered dietary history. The aims of the project will be
addressed through coordinated techniques of single taste bud labels, peripheral taste nerve recordings, central
nervous system tract tracing, extensive analyses of synaptic elements at the light and electron microscopic
level, and optogenetic recovery of function experiments. These studies will provide new and important
information about the development and plasticity of the central gustatory system, the interplay between the
immune and gustatory systems during development, and more broadly, they will be useful in determining the
role that the maternal diet and taste-elicited activity have on organizing the developing sense of taste.

Public health relevance
Narrative/Public Health Relevance One of the fundamental questions in neuroscience is how circuits in the brain are formed during development and how they are modified by experience. The proposed research program seeks to define fundamental aspects of how circuit development in the gustatory brainstem is influenced by neural activity and by non- activity dependent factors. Since taste plays a key role in food acceptance and rejection, our work may lead to new insights into how preferences and aversions are formed during development and how modifiable these circuits are through experience.